Polarity Signals Coordinate Neuronal Differentiation & Nuclear Organization

Project Summary
Abstract: During neural development, billions of nerve cells go through a highly orchestrated sequence of
differentiation, migration, and forming connections with other neurons. Our recent research has shown that
proteins involved in controlling the directionality of neuronal migration also have a role in controlling the
organization of chromatin in the cell nucleus, which is linked to neuronal differentiation. This exciting discovery
could lead to a better understanding of developmental disorders and pediatric cancers where neuronal
differentiation is compromised.
Our previous research demonstrated that two specific proteins, Pard6a and Pard3, play a crucial role in neuronal
development in the cerebellar granule neuron and are antagonized by another protein, Siah2, which is present
in neuronal precursors. Our latest findings have shown that neuronal precursors compact their chromatin and
that Pard6a and Siah2 are surprisingly located in the nucleus during neuronal development. Loss or gain of these
proteins can significantly impact chromatin compaction. This suggests that the proteins involved in controlling
neuronal polarity in migration and adhesion are directly linked to changes in chromatin organization during
neuronal development. This work implies a premise that polarity signaling directly links nuclear reorganization to
neuronal differentiation. We will build on our polarity signaling expertise to mix in vivo genetics and ex vivo
mechanistic studies with transformative single-cell imaging technologies to explore these aims:
Aim1: Define how Siah2 restrains CGN nuclear condensation and chromatin compaction.
Aim 2: Define how Pard6a promotes CGN nuclear condensation and chromatin compaction.
We will use advanced imaging technology, in vivo genetics, and ex vivo mechanistic studies to explore these
findings further. If successful, this research will provide a new conceptual model of how neuronal differentiation
promotes chromatin compaction and nuclear condensation. Enhancing our fundamental knowledge of these
basic cell biological processes in neurodevelopment can lead to new diagnostics or treatments for
neurodevelopmental disorders and pediatric cancers where neuronal differentiation is compromised.

Public health relevance
Project Narrative During neural development, the maturation of nerve cells drives fundamental cellular processes that assemble neuronal circuitry. This proposal studies the mechanisms governing the cell biology of neuronal differentiation and how developing neurons organize their chromatin during this process. The imaging tools and conceptual advances developed by this proposal will not only expand our knowledge of neural development but could lead to new diagnostics and treatments for neurodevelopmental disorders, such as pediatric cancers or developmental defects associated with pre-term birth.